Dynamic Fibrous Scaffolds for Repairing Dense Connective Tissues

Abstract
Fibrous tissues of the musculoskeletal system (e.g., the knee meniscus) are plagued by their poor intrinsic
healing capacity. In the previous funding cycles, we developed enabling technologies including multi-fiber
scaffolds to introduce various temporal and structural signals towards the repair of meniscal tissue. We used
these scaffolds to engineer constructs with properties and organization similar to native tissues (1st cycle) and
then developed scaffolds to enhance endogenous tissue repair through the delivery of factors to recruit local
cells (2nd cycle). The overall objective of this renewal is to further improve endogenous meniscus repair with
engineered scaffolds through the appropriate temporal and spatial orchestration of factor delivery, to first (i)
soften nuclei in cells (via a temporary reduction in heterochromatin content) near the injury site and then (ii)
recruit and stabilize the phenotype of these cells within the repair scaffolds. We hypothesize that the delivery of
these factors will permit recruitment of viable endogenous cells from the meniscus to the scaffolds and that the
spatial control of these factors will improve scaffold colonization, even with thick scaffolds. We will employ
composite scaffolds (developed during the previous funding cycles) that provide a stable fiber fraction
(polycaprolactone (PCL), to provide an instructional pattern and mechanical stability), a sacrificial fiber fraction
(polyethylene oxide (PEO), to define initial scaffold porosity and provide early release of factors into the
environment), and an engineered hyaluronic acid (HA) fiber fraction (that degrades over weeks and releases
factors in a sustained fashion). To address our hypotheses, the first Aim will utilize in vitro microfluidic-
platforms to investigate the timing and dosing of nuclear-softening (Trichostatin A), chemotactic (platelet-
derived growth factor), and fibro-chondrogenic factors (transforming growth factor-β3) to alter nuclear
mechanics, cell recruitment, and promote resumption of the cellular phenotype of cells migrating into fibrous
scaffolds from meniscal tissue. In the second Aim, we will control release from either the entire scaffold (as
before) or from an internal layer (newly proposed) across a variety of scaffold thicknesses and release rates to
promote population of thick scaffolds. This Aim will be conducted using our recently developed subcutaneous
model of meniscus tissue repair. In the third Aim, scaffolds will be implanted into meniscal defects in Yucatan
minipigs to evaluate their efficacy in a clinically relevant defect model. If successful, these studies and
technologies will advance our understanding of the use of engineered scaffolds for endogenous meniscus
repair and provide a step towards clinical translation.

Public health relevance
Narrative Menisci of the knee cushion our joints during normal loading, but are commonly injured. Unfortunately, healing of the meniscus in adults is limited, and current treatment options do not restore function, resulting in degeneration of the underlying cartilage. To address this, we engineer fibrous scaffolds with tailored release of factors that sequentially promote endogenous cell migration from the surrounding tissue and direct differentiation upon arrival at the wound site, and test these in a large animal model of meniscus repair.